Ex vivo skin wound infection model for Vibrio vulnificus pathogenesis

Project Summary
Rates of the disease human vibriosis caused by Vibrio infections are steadily rising world-wide, correlating
with rising ocean temperatures and increased Vibrio abundance and broader distribution in marine
ecosystems, coastal waters, and aquaculture farms. Multi-drug resistant Vibrio isolates are becoming more
prevalent, limiting the efficacy of traditional antibiotic therapy in this rapidly progressing acute disease. Thus,
there is an urgent need to develop alternative and combinatorial therapeutics for treatment of Vibrio infections.
In Vibrio species, the major pathway that controls pathogenesis is quorum sensing: cell-cell chemical
communication that bacteria use to control gene expression in response to changes in the number of bacteria
around them. In all pathogenic Vibrios, the central quorum sensing regulator LuxR/SmcR is necessary for
virulence in hosts and controls genes critical for pathogenesis: proteases, hemolysins, cytotoxins,
siderophores, and biofilms. Thus, LuxR/SmcR proteins are promising targets for drug development to directly
inhibit quorum sensing and prevent Vibrio pathogenesis. Thiophenesulfonamide compounds such as PTSP (3-
phenyl-1-(thiophen-2-ylsulfonyl)-1H-pyrazole) are potent, stable, fast-acting, specific inhibitors of LuxR/SmcR
proteins, but do not affect Vibrio cell growth or viability even at high concentrations. PTSP compounds block
protease and hemolysin production and protect shrimp from Vibrio infection in vivo. Thus, the long-term goal of
this research program is to develop PTSP and its derivatives into anti-quorum sensing therapeutic compounds
that treat vibriosis disease in humans. The primary causative agent of acute illness, morbidity, and mortality
from human vibriosis disease is Vibrio vulnificus. The proposed research aims to assess the efficacy of these
compounds at preventing colonization, decreasing virulence, and treating established V. vulnificus infections.
To accomplish these goals, the research team will employ a novel ex vivo human skin infection model for
wound infections. Pilot experiments demonstrated rapid V. vulnificus colonization and degradation of the
dermal-epidermal tissues, which are similar to phenotypes observed in the clinic. The proposed research will
apply the three-dimensional (3D) imaging technique called MiPACT to the ex vivo skin model to visualize V.
vulnificus cells in situ. The powerful combination of the ex vivo skin infection model and 3D-imaging method
will enable the research team to accomplish two primary aims: 1) examine the role of core virulence factors
during early infection and 2) assess the efficacy of PTSP treatment on V. vulnificus colonization. Collectively,
the proposed research will enable ex vivo studies of human skin reactions to V. vulnificus colonization and
provide a broad platform for observation of virulence factor effects via 3D-microscopy, in order to evaluate
thiophenesulfonamide compound efficacy against V. vulnificus skin infections.

Public health relevance
Project Narrative Pathogenic Vibrio bacteria cause the acute disease vibriosis in humans, resulting in rapid symptom progression and high mortality if untreated. Due to globally increasing rates of vibriosis and multi-antibiotic resistant Vibrio strains, we aim to develop alternative therapeutic approaches to treat vibriosis disease. We will utilize an ex vivo skin wound infection model to study Vibrio vulnificus virulence factor production and treatment with novel antibacterial compounds.